HALOPERIDOL PHARMACODYNAMICS AND CLINICAL RESPONSE IN SCHIZOPHRENIA

As part of a standardized research sequence in the NIMH Intramural Clinical Program located at Saint Elizabeths, patients with schizophrenia are withdrawn from neuroleptic medication and then (after clinical relapse) treated with a fixed dose of haloperidol. This has in turn allowed initiation of a variety of studies regarding the pharmacokinetics of haloperidol. Other pharmacological issues examined in these patients are drug-drug interactions (specifically involving haloperidol and both nicotine and retinoic acid). In addition, basic science investigations regarding these drugs are being conducted.